Aurora NCORP Community Site

PROJECT SUMMARY
The Aurora NCORP community site will enroll patients into a variety of NCI-sponsored clinical trials.
Advocate Health serves approximately 20,000 newly diagnosed adult and pediatric cancer patients
annually throughout Wisconsin and Illinois. Specifically, the Aurora NCORP will:
• Increase accrual to NCI-sponsored clinical trials in adult and pediatric research.
• Expand our trial portfolio to reflect the depth and breadth of NCI-sponsored clinical trials.
• Conduct cancer care delivery research that utilizes the expansive resources and expertise
available throughout Advocate Health.
Ultimately, the Aurora NCORP will involve more patients in clinical research that will lead to improved
patient outcomes.

Public health relevance
PROJECT NARRATIVE The Aurora NCORP community site will enroll patients in an expanded portfolio of NCI-sponsored clinical trials. The program is built on a foundation of high-quality cancer care, an experienced leadership structure and a strong clinical research infrastructure.